Novel Translational Studies for Psoriasis

In the clinical arena, we have recently completed two translational studies in patients with severe psoriisis. In the first study, we treated patients with human interleukin-10 (rhIL-10), a potent anti-inflammatory cytokine. rhIL-10, when compared to placebo, induced modest improvement in psoriatic lesions. However, this clinical response was not maintained over the 12 week study period, despite laboratory evidence that pro-inflammatory cytokine production by blood cells was continually suppressed by rhIL-10. Recently, we have completed a second study in patients with severe psoriaisis. We administered Micellar Paclitaxel to 10 patients with severe and previously treatment-resistant psoriaisis. All 10 showed 50-75% improvement in their skin disease with minimal side effects. As was done in the rhIL-10 study, experiments were performed in my laboratory on patient samples to help gain insight into potential biologic correlates of clinical efficacy.